Epigenomic control of antimicrobial immunity in the intestine

PROJECT SUMMARY
Intestinal epithelial cells (IECs) that reside at the interface between the microbiota and diverse immune cell
populations are critical for initiating and maintaining
However, the mechanisms underlying how IECs
tissue-intrinsic defenses needed to quickly combat infection.
orchestrate the dynamic cross-talk between microbiota,
epithelial cells, and lymphocytes remain poorly defined. Epigenetic-modifying enzymes represent a powerful, but
poorly understood, interface by which mammalian cells can respond to microbial signals and regulate host
response. We recently identified that IEC deletion of the epigenetic regulator HDAC3 in utero inhibited
microbiota-dependent regulation of IECs and impaired activation of intestinal immune cells during infection.
However, it remains unknown how HDAC3 in IECs actively governs intestinal immunity or sustains microbiota-
sensitive defense against enteric infection. The goals of this proposal are to interrogate how differentiated and
progenitor IECs actively control intestinal immune cell dynamics and microbiota-sensitive pathways needed for
antibacterial immunity through epigenetic regulation. Based on new preliminary findings, we hypothesize that
HDAC3 is an essential epithelial factor that (1) dynamically coordinates resident lymphocytes in the intestine and
(2) primes short- and long-term IEC responsiveness to infection by integrating signals from the microbiota.
Employing Citrobacter rodentium, a murine model of pathogenic human Escherichia coli infection, along with an
exciting array of inducible transgenic mouse tools, germ-free mice, and human organoids, three specific aims
are proposed to investigate these hypotheses. We will (i) interrogate how active regulation of IECs by HDAC3
directs tissue-resident lymphocyte dynamics and test how this epithelial-immune cell relationship is
mechanistically controlled, (ii) directly examine how the microbiota promote epithelial antimicrobial secretion
during infection, and (iii) employ reporter mice to define whether epigenetic regulation of stem cells mediates
how the microbiota sustains long-term defense in the intestine. We will also translate our murine studies to
human intestinal organoids to provide mechanistic insights on the role of HDAC3 and epigenetics in host-microbe
interactions in human intestine. This work will uncover novel mechanisms for how IECs integrate microbial
signals to instruct intestine-intrinsic immunity and guide design of next generation therapeutics that can
epigenetically prime the intestine to effectively defend against enteric infections.

Public health relevance
PUBLIC HEALTH RELEVANCE Intestinal tissues are in constant contact with diverse beneficial and pathogenic microbes, highlighting the need for orchestrating complex signals to sustain intestinal immunity. The goals of this proposal are to understand how epithelial cells instruct dynamic and long-term protective immunity during intestinal bacterial infection. The outcomes of these studies will direct development of next generation immunotherapies that prime effective intestinal immunity.